The Effectiveness of Cochlear Implants in Real-World Settings for Mild Cognitive Impairment and Dementia in Older Adults with Age-Related Hearing Loss

PROJECT SUMMARY ABSTRACT
Age-related hearing loss (ARHL) results from the cumulative effects of aging on the auditory system. There
is growing evidence linking ARHL with cognitive impairment and increased risk of Alzheimer’s disease and
related dementias. In fact, the 2017 Lancet Commission for Dementia Prevention, Intervention and Care found
that hearing loss is associated with the highest relative risk of dementia (RR 1.9) among 9 potentially modifiable
risk factors. It is hypothesized that poor peripheral encoding of sound due to ARHL contributes to cognitive
impairment by increasing cortical resources to auditory decoding from memory and other cognitive domains.
Research shows an association between the severity of hearing loss and disability in activities of daily
living, including shopping, preparing meals and household chores. Older adults with ARHL become socially
isolated as communication problems increase, resulting in emotional and cognitive difficulties. The goal of this
study is to understand the effect of cochlear implants and hearing aids using real-world data documenting daily
performance in study subjects’ natural environments as a predictor of cognitive impairment, or progression
from mild cognitive impairment to dementia in people with ARHL. Six groups of individuals, 65+ years of age,
will be studied: 1) cochlear implant (Implant) users with normal cognition; 2) Implant candidates who
naturalistically retained hearing aids (HA retainers) with normal cognition; 3) Implant users with mild cognitive
impairment (MCI); 4) HA retainers with MCI; 5) normal hearing/normal cognition; and 6) normal hearing with MCI.
Data from a smartphone ecological momentary assessment (EMA) system is this study’s primary outcome
measure, including patient-reported outcomes collected in real-time across multiple domains: 1) listening
environment; 2) hearing-related function; 3) hearing loss-related mental health; and 4) cognitive function.
Aim 1. Compare the cross-sectional association of Implants or HAs on real-world EMA outcomes in ARHL
with normal cognition. Hypothesis: Implants will be associated with better EMA outcomes (auditory function,
cognitive performance, social interaction, psychosocial wellbeing) as compared to HA retainers.
Aim 2. Compare the longitudinal effects of the use of Implants or HAs in AHRL with and without cognitive
impairment on cognitive function, using real-world EMA outcomes and a neuropsychological battery.
Hypothesis: Implants will be associated with better cognitive performance and less cognitive decline than HA
retainers as measured by both EMA cognitive items and by neuropsychological testing in those with baseline
ARHL-related MCI.
Aim 3. Deploy study data in our visual analytics platform for precision medicine, clinical decision-support,
and data-sharing of hearing/cognitive outcomes by 1) identifying predictor variables, 2) developing
individualized predictive models for Implants/HAs, and 3) enabling large scale data-sharing of these models for
all clinical and research stakeholders.

Public health relevance
PROJECT NARRATIVE There is growing evidence linking age-related hearing loss (ARHL) with cognitive impairment and the increased risk of Alzheimer’s disease and related dementias. Recent research demonstrated an association between the severity of hearing loss and disability in routine daily activities. The goal of this study is to understand the effect of cochlear implants and hearing aids using real-world data documenting daily performance in study subjects’ natural environments to prevent the onset of cognitive impairment, or progression from mild cognitive impairment to dementia in people with ARHL.